ECCO - Evaluation of Outcomes Associated with Community Care Prescribed Opioids

Background: Starting in 2013, VA's Opioid Safety Initiative expanded resources for pain management and
successfully reduced high-risk opioid prescriptions. MISSION Act expansion of VA Community Care (CC)
includes authorization for CC providers to prescribe opioids for outpatient treatment of acute and chronic pain,
but charges VA with ensuring that these are safely and appropriately dispensed from VA pharmacies. Veterans
who use both VA and non-VA services may be particularly at risk for opioid-related harms, but past work was
conducted before MISSION Act implementation and mainly addressed services paid by non-VA insurers.
Although the main goal of MISSION Act is to improve Veterans' health care access, it remains unclear how CC
expansion has impacted opioid safety and patient-reported outcomes for Veterans.
Significance & Impact: Reducing opioid-related harms and improving treatment for chronic pain are high-
priority goals for VA HSRD and clinical services. Given increasing numbers of Veterans now using CC, there is
an urgent need to better understand Veteran, community, and VA facility factors associated with receipt of CC
opioids, and explore potential differences in higher-risk CC prescriptions, compared with VA-prescribed opioids.
Moreover, examination of Veteran-centered pain outcomes will address the ORD-wide priority of increasing real-
world impact of VA research.
Innovation: This study will be the first to evaluate Veteran-centered outcomes associated with CC opioids,
including functioning and health-related quality of life. The proposed design also includes multiple elements to
rigorously address multilevel confounders, including variation in community opioid prescribing patterns. We use
innovative causal estimation methods in our predictive models, in order to understand the relative importance of
a variety of factors in contributing to likelihood of receiving CC opioids.
Specific Aims: 1) Identify key multilevel predictors of receiving any CC vs. only VA-prescribed opioids for
outpatient pain treatment, and evaluate potential differences in higher-risk opioid prescriptions; and 2) for a
national prospective cohort of Veterans receiving any CC vs. only VA-prescribed opioids, examine differences
in patient-reported outcomes and acute care episodes over 1 year.
Methodology: First, we will conduct a retrospective analysis using national VA data from January-December
2021 to determine key Veteran, community, and VA facility factors that predict receiving any CC-prescribed
opioids. Then, we will use propensity score adjusted models to examine differences in higher-risk opioids
prescriptions between Veterans receiving any CC vs. only VA-prescribed opioids. For Aim 2, we will enroll a
prospective national cohort to evaluate outcomes associated with receiving any CC vs. only VA-prescribed
opioids. We will use survey data (at baseline and 1-year follow-up) to assess patient-reported outcomes (pain-
related functioning, pain severity, quality of life, and satisfaction with pain care) and acute care episodes
(hospitalizations and emergency department visits).
Implementation & Next Steps: We will disseminate study results to various stakeholders, including Veterans,
VA staff, and VA leadership. The exact next steps will depend on the nature of findings and their immediate
relevance to different stakeholders. We will work with our operational partners in the VA Program for Pain
Management, Opioid Safety and PDMP, Office for Medication Safety, and Office of Community Care to develop
the dissemination plan. We will also seek feedback from our Veteran Engagement Panel to inform dissemination
efforts. We will communicate findings through presentations and publications, cyber-seminars, and involvement
with groups or networks focused on improving CC services and pain treatment for Veterans.

Public health relevance
The VA Opioid Safety Initiative has reduced high-risk opioid prescribing and improved pain treatments for Veterans in VA care. To enhance access and improve health outcomes for Veterans, the MISSION Act expanded eligibility criteria for VA purchased services provided by non-VA community clinics (VA Community Care [CC]). VA is still charged with ensuring high-quality care for Veterans receiving CC services, including for outpatient treatment of pain. It is unclear how CC expansion has impacted opioid safety and patient-reported outcomes for Veterans receiving CC-prescribed opioids, particularly given known challenges in care coordination and health care communication for CC services. The proposed project will examine factors associated with receiving CC- prescribed opioids, and evaluate outcomes for Veterans who receive any opioids CC-prescribed opioids vs. only VA-prescribed opioids. These results are essential for developing future strategies to better integrate VA and non-VA provided services, and improving outcomes for Veterans receiving CC services for pain treatment.